Turbo Eye Drops to Treat Ocular Toxicity and Blindness from Sulfur Mustard

ABSTRACT
Sulfur mustard gas (SM), a vesicating and warfare agent, has been used in many wars since World War I; most
recently in Syria. SM rapidly penetrates the eye on contact and causes blindness by injuring corneal tissue-
organization and function. Clinically, patients show a pathology termed as Mustard Gas Keratopathy that involves
severe ocular inflammation, recurrent epithelial-erosions, epithelial-stromal separation limbal stem cell
deficiency, corneal ulceration, haze and neovascularization. MGK pathophysiology is biphasic including acute
and delayed-onset, and involves multiple mechanisms. We developed a novel, multimodal, non-steroidal topical
ophthalmic drops, Turbo Eye Drop (TED), containing 4 FDA-approved generic drugs with differing mode of
action, and stable at ambient temperature. Our pilot studies found that topical TED efficaciously treats acute and
delayed-onset MGK in rabbits in vivo and human cornea ex vivo without significant side effects. Our central
hypothesis is that topical TED treats acute and delayed-onset MGK in vivo by curbing SM-induced early
inflammatory responses, extracellular matrix degradation, and production of excessive pro-fibrotic and pro-
angiogenic factors without significant side effects. This project tests two novel hypotheses to establish an
efficacious and safe topical therapy for acute and delayed-onset MGK in vivo, using four specific aims: Aim-1
defines TED treatment for acute MGK in vivo by testing the hypothesis that increasing frequency and duration
of TED application will potently treat acute MGK and blindness without significant side effects. Aim-2 establishes
TED treatment for delayed-onset MGK in vivo by testing the hypothesis that low TED topical dosing for longer
duration will effectively cure delayed-onset MGK without issues in rabbits. Aim-3 uncovers mechanisms used by
TED in mitigating acute and delayed-onset MGK in vivo and in vitro. Aim-4 secures intellectual property rights,
develops regulatory strategies, and advances TED topical ophthalmic drops as an antidote for SM-induced
ocular injury towards human application. This will be accomplished using an established SM-vapor rabbit in vivo
and human cornea organ culture ex vivo models, GMP-grade TED eye drops, and monitoring eyes in live rabbits
in a time-dependent manner with clinical eye exams and diagnostic imaging. The characterization of
mechanisms used by TED in mitigating MGK will be studied using corneal tissues collected after euthanasia by
measuring integrity of corneal epithelial basement membrane, epithelial-stromal organization, and collagen fibril
arrangement using qPCR, ELISAs, immunofluorescence, H&E, and transmission electron microscopy
techniques utilizing our published methods. Successful completion of the project will lead to the development of
an effective and safe therapy for acute and delayed MGK and medical countermeasure to minimize ocular
obliteration caused by the accidental or intentional use of SM in humans, and therefore will have very high impact
in field and public safety.

Public health relevance
PROJECT NARRATIVE Sulfur mustard (SM), a vesicant and warfare agent, was recently used by terrorists in Syria. No specific therapy for SM-induced ocular toxicity exists currently. Recently, we developed a novel multimodal non-steroidal topical ophthalmic solution, Turbo Eye Drop (TED), and found it highly potent in counteracting SM-induced blindness and ocular damage in rabbits in vivo. This project establishes the most effective treatment regimen, safety, and mode of action of TED, and leads bench-to-bedside translational development of first potent and safe antidote against SM-induced blindness and ocular injury in vivo.